REGULATION OF MHC CLASS II GLYCOPROTEIN STRUCTURE AND FUNCTION

The orderly transport of proteins within the secretory pathway of eucaryotic cells is mediated by the specific recognition and fusion of transport vesicles with distinct target organelle-associated membrane proteins termed SNAREs. In our attempt to identify the transport route taken by MHC class II molecules to intracellular antigen processing compartments, we have screened a human B cell cDNA library in search of genes regulating vesicular traffic in lymphocytes. We have isolated the cDNA encoding human syntaxin 5, a transmembrane protein whose rat and yeast homologs regulate endoplasmic reticulum-to-Golgi apparatus transport. We have also isolated the cDNA for SNAP-23, a ubiquitously expressed membrane- ssociated protein potentially involved in facilitating transport vesicle docking and fusion. We are also investigating the role that post-translational modification plays in the regulation of intracellular MHC class II transport. We have identified the phosphorylation sites on the MHC class II-associated invariant chain, and are working to understand the regulation of invariant chain phosphorylation in the context of MHC class II-restricted antigen processing and presentation.